Development of a Novel Chemokine Receptor Antagonist as a Treatment for Opioid Use Disorder

7. Project Summary
Over 2.1 million Americans suffer from opioid use disorder (OUD) resulting in 47,000 deaths annually. Individuals
seeking treatment must deal with limited access to qualified healthcare professionals, as well as barriers to
getting medication assisted treatment (MAT). Common MAT treatments utilizing buprenorphine often require
patients to experience withdrawal symptoms for several days prior to MAT initiation. Further, the stigma of OUD
treatment, which could be reduced if patients received ambulatory care, acts as an additional hindrance to access
and treatment. There is a paucity of options available for these individuals and the medical staff who treat them,
as methadone, buprenorphine and naloxone, the standards of care, are often not successful in achieving
treatment goals. Emerging evidence demonstrates that brain chemokine receptors control dopamine reward
pathways and influence behavioral effects of drug abuse which can be blunted by chemokine receptor
antagonists. CBP proposes to expand MAT capabilities for OUD with RAP-103, a small orally stable chemokine
receptor antagonist peptide that block’s opioid acquisition, maintenance, and withdrawal. Our evidence indicates
that RAP-103 has significant safety and efficacy advantages as a non-opioid for MAT use that blocks opioid self-
administration in fixed-ratio tests that show reduction in total opioid consumed and in progressive-ratio
experiments that show greatly reduced motivation to maintain opioid use. Additionally RAP-103 mitigates signs
of naloxone induced opioid withdrawal in a rodent model of morphine dependence. In this project, our objective
is to further demonstrate the feasibility of RAP-103 as a MAT agent and to progress to human testing. We intend
to do this by optimizing the lowest dose at which RAP-103 mitigates opioid self-administration in progressive-
ratio experiments in male and female rats. In view of the unique mechanism of RAP-103 action via chemokine
receptor antagonism we will identify chemokine and cytokine changes in mesolimbic (VTA and nucleus
accumbens) brain reward areas to provide a mechanism for how RAP-103 may mitigate the rewarding effects of
opioids and other drugs of abuse. CBP has been conducting pre-clinical pharmacokinetic and toxicokinetic safety
testing toward fulfilling requirements for filing an IND and conducting first-in-human safety testing. CBP has
assembled a team of experienced MAT clinician/researchers to plan a clinical development program for an OUD
use. We propose to conduct the additional pre-clinical safety tests that would support filing of an IND for an OUD
treatment use of RAP-103 at the end of the program. CBP will advance clinical development of RAP-103 as a
MAT for OUD with goals to provide safer treatment with no abuse risk, improve patient access, adherence,
tolerance and treatment. The superior safety profile (no respiratory depression and abuse or diversion potential),
reduced motivation to maintain opioid use, mitigation of withdrawal symptoms and oral bioavailability by once
daily dosing would make RAP-103 a highly valuable addition to the OUD MAT toolbox, initially as an adjunctive
therapy that can help overcome the underutilization of MAT access and use.

Public health relevance
8. Project Narrative Medication-assisted treatments (MAT) for opioid use disorders (OUDs) can cause suffering from common side effects, may produce opioid withdrawal symptoms, don’t work for everyone, and are underutilized. Expanding the treatment options for OUD has the potential to increase treatment rates and provide more effective, individualized care for people with OUD and potentially to engage more people with treatment-resistant OUD in receiving care. Creative Bio-Peptides is developing oral RAP-103, a safe non-opioid treatment for OUD that can block motivation to maintain opioid use and mitigate signs of opioid withdrawal, as a novel treatment for substance use disorders.